Engineering Nanobodies To Study Beta Subunit-Specific Voltage-Gated Calcium Channel Complexes in Pancreatic Beta Cells

PROJECT SUMMARY Diabetes is a growing pandemic that is characterized by insufficiency of insulin, a key hormone of glucose maintenance. Ca2+ influx through voltage-gated calcium channels (VGCCs) is necessary for glucose-stimulated insulin secretion in pancreatic β-cells (PβCs), and has also been implicated in maintaining PβC identity, an important regulatory point in diabetes progression. VGCCs are thus a potential locus for both PβC-dependent pathophysiology and therapy. These channels are multi-subunit complexes comprised minimally of pore-forming α1 subunits assembled with auxiliary (β, α2δ,and γ) proteins. In heterologous cells, CaVβ subunits (β1-β4) are powerful regulators of VGCCs by controlling α1 subunit trafficking and tuning channel gating. A central unresolved question is: how does Ca2+ influx via VGCCs give rise to divergent functions in PβCs such as insulin secretion and excitation-transcription coupling? It is likely that differential sorting of VGCCs into spatially distinct macromolecular complexes is a key underlying principle that enables such functional diversification of VGCC Ca2+ signals. PβCs express multiple CaVα1 and β subunits? the precise functional roles of distinct CaVβs in PβC physiology and pathophysiology are unclear. Nevertheless, CaVβs are downregulated in rodent models of diabetes, and knockout models suggest they play a role in glucose homeostasis. I hypothesize that in PβCs distinct CaVβs are instrumental in organizing VGCCs into discrete macromolecular complexes with specialized functions. A significant barrier in our capacity to rigorously assess the functional roles of CaVβ molecular diversity in excitable cells, including PβCs, is the inability to inhibit VGCCs based on the identity of their resident CaVβ. Here, I propose to develop novel genetically-encoded CaV channel blockers that enable inhibition of CaVβ-specific VGCC complexes, and apply them to decipher signaling functions of CaVβs in PβCs. The approach exploits a bioengineering method to generate genetically-encoded VGCC inhibitors termed Channel Inactivation by Membrane-tethering of an Associated Protein (ChIMP) pioneered by our lab. In this proposal, I combine development of Cavβ isoform-selective nanobodies with molecular biology, electrophysiology, flow cytometry, fluorescence resonance energy transfer (FRET), ion channel engineering, and biochemistry to address two specific aims. First, I will develop and engineer nanobodies to selectively inhibit VGCCs on the basis of their resident CaVβ. In my second aim I will elucidate the functions of CaVβ specific VGCC complexes in pancreatic β-cells.

Public health relevance
PROJECT NARRATIVE Diabetes is a growing pandemic that affects half a billion people across the globe, highlighting the importance for improved therapies. The focus of this work is on voltage-gated calcium channels (VGCCs), which are critical for multiple processes that are disrupted in diabetic pancreatic β cells. We create novel tools to probe the diverse functions of VGCCs in these insulin-producing cells, with the ultimate goal of identifying potential therapeutic targets for the treatment of diabetes.